Project 1: OPC-ORN

ABSTRACT: PROJECT 1 (OPC-ORN)
Current standard-of-care external beam radiotherapy (EBRT) for human papillomavirus (HPV)-associated
oropharyngeal cancer (OPC) offers high cure at the cost of severe delayed adverse sequelae.
Osteoradionecrosis (ORN) is a highly morbid, delayed bone-related complication that at early stages causes
pain and multiple dental procedures, and later stages progresses to jaw fracture, possible oral fistula, and
requires major oral surgery for removal of de-vascularized mandibular bone, thus with substantial implications
on healthcare costs, function, and quality of life. Given the excellent outcomes for HPV-associated OPC and
long-term survival of these typically younger patients, early detection, surveillance, and mitigation of delayed
adverse sequelae such as ORN to improve survivorship represents a major healthcare challenge. Through our
studies we have established elevated DCE-MRI Ktrans as a candidate diagnostic biomarker of mandibular injury
under FDA-NIH BEST (Biomarkers, EndpointS, and other Tools) definitions, as well as a reasonably likely
surrogate endpoint of ORN. A significant knowledge gap exists relative to the actual incidence, symptom
trajectory and potential biomarkers of ORN development after post-radiation latency this growing OPC survivor
population and innovative strategies are necessary to identify and monitor this chronic/delayed ORN-associated
therapeutic sequela. The challenge of managing therapy-related normal tissue injury represents a significant
unmet public health need. Our work promotes the overarching hypothesis that subclinical mandibular injury
is prevalent before symptomatic manifestation, can be risk-stratified by dosimetric and clinical criteria
before observable ORN, is presaged by both image biomarker and symptomatic progression, and can
be potentially altered by hemorheologic drug candidates. We will develop our approach through the
following Specific Aims (SAs). First, we will prospectively characterize the natural history, temporal symptom,
and candidate imaging biomarker trajectories in OPC survivors at elevated risk of ORN. We aim to prospectively
characterize time-to-ORN disease states and related toxicity events via objective measures, and validate clinico-
dosimetric time-to-event models, including modifying treatments (e.g., proton therapy, pentoxifylline) and
imaging biomarkers. Second, we will define potential toxicity profiles as phenotypic biomarker for ORN-related
toxicity clusters and marker for patient-centered tracking of ORN outcomes. Third, we will evaluate in vivo
revascularization profiles of hemorheologic drug candidates (pentoxifylline vs cilostazol) within a pragmatic
“window of opportunity” trial for patients with advanced ORN planned for image-guided segmental
mandibulectomy/reconstruction. We expect to provide critical knowledge regarding clinical markers, trajectories,
and mitigation of ORN to enhance our efforts to monitor and treat this devastating delayed sequela of curative
treatment.

Public health relevance
NARRATIVE: PROJECT 1 (OPC-ORN) Osteoradionecrosis (ORN) is a highly morbid, delayed bone-related complication from radiation therapy with substantial impacts on healthcare costs, function, and quality of life. Our work explores the potential to characterize subclinical mandibular injury that is prevalent before symptomatic manifestation of observable ORN. Validation of risk stratification by dosimetric, imaging, and clinical criteria would enhance our efforts to monitor, mitigate, and treat this devastating delayed sequela of curative treatment.